Community-onset urinary tract infections caused by extended-spectrum beta-lactamase-producing Escherichia coli in women of diverse backgrounds

PROJECT SUMMARY
This is an application for a Career Development Award for Dr. Eva Raphael, a clinical research fellow and
future Assistant Professor at the University of California, San Francisco. Her career goal is to be a family
medicine-trained clinician-researcher improving prevention and outcomes for community-onset antimicrobial
resistant infections by combining epidemiological methods to identify novel risk factors that can be intervened
upon. This award will provide her with the training and research experience to: (1) examine demographic and
neighborhood-level risk factors for community-onset urinary tract infections (UTI) caused by ESBL-producing
Escherichia coli (ESBL-UTI) among women; (2) identify complications for community-onset ESBL-UTI and
associated risk factors; and (3) investigate whether the temporal and geographic trends in prevalence of
community-onset ESBL-UTI correlate with trends in prevalence of predominant E. coli genotypes. To facilitate
successful completion of these activities, Dr. Raphael has assembled an ideal mentoring team comprised of
two co-primary mentors, Dr. Maria Glymour, an expert in social epidemiology methods and health inequities
research, and Dr. Henry Chambers, an expert in clinical antimicrobial resistance research, and a co-mentor,
Dr. Alison Huang, an expert in genitourinary health in older women and patient-reported outcomes. In addition,
Dr. Raphael will have 2 advisors: Dr. Salma Shariff-Marco, an expert in spatial epidemiology and neighborhood
effect on health outcomes, and Dr. Sara Tartof, an infectious disease epidemiologist who focuses on
antimicrobial resistance.
The prevalence of antimicrobial resistant infections is increasing worldwide, both in healthcare and
community settings. While antibiotic use is a major driver for selection of antimicrobial resistant organisms,
novel risk factors are beginning to be identified for transmission of such organisms, especially in diverse
populations. Moreover, new evidence suggests antimicrobial resistant infections, particularly UTI, may occur as
community outbreaks. Therefore, it is essential to further examine risk factors other than antibiotic use for UTI
caused by antimicrobial-resistant E. coli, in particular ESBL-UTI, and whether they occur as outbreaks in
diverse communities. Dr. Raphael will build on findings from prior work showing that prevalence of community-
onset ESBL-UTI has increased in a San Francisco public safety-net healthcare system and differed by
race/ethnicity and age. Dr. Raphael will employ causal inference methods to identify novel individual and
neighborhood risk factors for ESBL-UTI compared to both non-ESBL antimicrobial resistant and susceptible
UTI and their complications (Aims 1 and 2). Through spatial analyses, geographic clusters of predominant E.
coli genotypes causing UTI, particularly ESBL-UTI, will be identified and compared to geographic distribution of
ESBL-UTI phenotypes (Aim 3). This work will be the basis of an R01 proposal for a longitudinal study
identifying multilevel risk factors and incidence of UTI recurrence and complications in a cohort of community-
dwelling women diagnosed with UTI.
Through a focused program of mentored training and coursework, the candidate will gain skills in: (1) social
epidemiology methods; (2) spatial epidemiology; and (3) patient-reported outcomes research methods as they
apply to community-onset infections. These skills will facilitate Dr. Raphael's transition to independence by
uniquely positioning her to address multilevel factors to improve community-onset infections outcomes in
diverse populations.

Public health relevance
PROJECT NARRATIVE Community-onset antimicrobial resistant (AMR) urinary tract infections (UTI) are a growing public health threat, particularly for women. The objective of this proposal is to identify individual- and neighborhood-level risk factors, predominant genotypes, and complications for UTI caused by extended-spectrum beta-lactamase- producing Escherichia coli (E. coli) (ESBL-E. coli), as well as temporal and spatial clusters of ESBL-E. coli. This approach requires the application of a combination of social, spatial, and molecular epidemiology methods which can be applied to other AMR infections.